Mechanisms and consequences of lipid accumulations in necroptosis

Project Summary
Lipids contribute to numerous cellular processes. The overarching goal of my laboratory is to study lipid regula-
tion and function in pathophysiological processes and identify targetable lipid-related pathways to better human
health. Necroptosis is a form of regulated cell death that contributes to the inflammatory components of many
diseases, including neurodegenerative and cardiovascular diseases and chronic inflammation. A hallmark of
necroptotic activity is the permeabilization of cellular membranes and the release of inflammatory molecules. My
laboratory has pioneered the efforts to study the involvement of lipids in necroptosis, leveraging untargeted lip-
idomics integrated with functional characterizations using pharmacological and genetic perturbations. We have
demonstrated that de novo lipid production increases via activated sterol regulatory binding element proteins
during necroptosis and results the accumulation of lipids that exacerbate membrane permeabilization. We have
thus far focused on very-long-chain fatty acid (VLCFA) accumulations in necroptosis and demonstrated that
VLCFA accumulation regulates the function of a key signaling protein of necroptosis, Mixed Lineage Kinase Like
Protein (MLKL), responsible for the permeabilization of the plasma membrane. Specifically, we showed that
MLKL undergoes S-acylation by VLCFAs, which increases its membrane binding and consequent plasma mem-
brane permeabilization in necroptosis. In the next five years, we will pursue three main research areas to answer
key questions toward better understanding the mechanism of activated lipid production in necroptosis and to
characterize the acylation of MLKL by VLCFAs in necroptosis.
What are lipid modulators of necroptosis? In Research Area 1, we will identify lipids that contribute to mem-
brane permeabilization in necroptosis. We will integrate state-of-the-art lipidomics approaches developed in my
lab with perturbation studies for functional investigations. This will reveal lipid groups linked to membrane per-
meabilization in necroptosis and lipid-related enzymes to reduce the inflammatory activity of necroptosis.
What causes lipid accumulation in necroptosis? In Research Area 2, we will investigate cellular and molec-
ular mechanisms that activate lipid production in necroptosis, integrating proteomics and imaging-based ap-
proaches. These results will advance our fundamental knowledge of lipid regulation in necroptosis.
How does S-acylation regulate MLKL functioning in necroptosis? In Research Area 3, we will focus on the
acylation of MLKL by VLCFAs, study the effect of acylation on MLKL fate during necroptosis and identify S-
acyltransferases that can incorporate these unusual fatty acids into MLKL.
Impact. Answering these questions will provide a fundamental understanding of the regulation of necroptosis by
lipids and pave the way for developing lipid-centric therapeutic strategies targeting necroptosis-mediated enter-
opathies.

Public health relevance
Project Narrative Necroptosis is a highly inflammatory form of cell death that is linked to numerous human pathologies, including chronic inflammation, neurodegenerative and cardiovascular diseases, and ischemia-reperfusion injuries. The proposed study will reveal a new lipid-related pathway that contributes to inflammatory activity during necropto- sis. We argue that targeting lipid production represents a novel therapeutic strategy to reduce the inflammatory response associated with necroptosis.